A Twin Study of Adolescent Alcohol and Drug Use Development: Leveraging Intensive Longitudinal Assessments

ABSTRACT
This is a response to PA-18-591: Administrative Supplements to Existing NIH Grants and Cooperative
Agreements (Parent Admin Supp Clinical Trial Optional). This parent project is part of the Intensive
Longitudinal Health Behaviors Network (ILHBN) established to collaboratively study factors that influence
dynamic health behaviors in individuals’ daily lives, using intensive longitudinal data (ILD) collection and novel
analytic methods. The network includes seven U01 projects and one U24 Research Coordinating Center
(RCC). This specific project leverages ILD in a genetically informative design to understand the development of
affect, mobility, and drug use in the context of the COVID-19 pandemic. Evidence suggests that the experience
of the COVID pandemic has caused increases in depressed mood and anxiety. These, in turn, have
implications for other health behaviors, such as substance use behaviors. Using intensive longitudinal data, we
will evaluate the nature and etiology of how individuals’ self-report affective dynamics and mobility patterns
vary over time, using phone-based location data to infer individuals’ activity space (typical area traveled for
routine everyday activities) as well as local covid conditions (e.g., case counts, lockdown policy) related to
COVID. We will test whether changes in local covid conditions are associated with each other and with
changes in affect, mobility, and substance use. Data from the parent project will be shared with the ILHBN
Research Coordinating Center to facilitate scientific efforts in other ILHBN studies.

Public health relevance
NARRATIVE Using intensive longitudinal data from multiple independently conducted studies, we will investigate the impact of the COVID-19 pandemic on human mobility and affect. These results will be replicated and extended to understand relationships with substance use using intensive longitudinal data in >700 twins collected from 2016 to the present day.